Core A. Administrative Core A

ABSTRACT
The Administrative Core will provide professional coordination and oversight to all projects and cores of this
program project grant. It will ensure smooth collaborative progress toward our research goals while
maintaining a high level of communication among our investigators and advisors and the National Cancer
Institute, ensuring compliance with all regulations, and working together with all relevant university units as
required for the timely completion of our research. Plans for organizational and administrative management,
scientific and fiscal management, and coordination and communication are presented. The Specific Aims
include convening and leading regular formal meetings of the investigators in this program project grant,
maintaining communication among the investigators, convening meetings of the External Scientific Advisory
Board and Internal Advisory Committee, reporting research results in annual Progress Reports to the NCI,
processing reimbursements and other related expenses, assisting in communication among the investigators
and with the NCI, compliance with all relevant university and government policies, coordination of data quality
assurance, and processing of publications.

Public health relevance
PROJECT NARRATIVE This program brings together highly respected scientists with expertise ranging from epidemiology and biostatistics to molecular aspects of tobacco control to determine why lung cancer risk from cigarette smoking is significantly different among five diverse ethnic/racial groups. The multidisciplinary team in this program follows this important lead to determine new approaches toward prevention of lung cancer, the leading cancer killer in the U.S.